Visual Augmentation Through Virtual Reality to Rehabiliate the Hand after Stroke

DESCRIPTION (provided by applicant): The driving force for this project reflects the need to develop scientifically grounded, empirically tested, and accessible therapies that maximize rehabilitation outcomes for restoring hand function after stroke. The candidate's short-term goal is to test a set of novel interventions, grounded in principles of neuroscience and motor learning, in reducing impairment & increasing hand function after stroke. His long-term goal is to make these interventions broadly accessible to stroke patients in environments beyond the clinic. Research project: Reinstating hand function (finger individuation, precision grip, & force production) is most daunting and least addressed after stroke. The candidate will couple specific visual feedback in virtual reality with impairment type to test if: 1) focusing visual feedback only to pertinent movement errors will restore finger individuation, 2) 'proper' visual feedback time-locked to motor commands will operantly shape better hand coordination patterns, and 3) virtual mirror visual feedback can reduce hand paresis. Career development plan: The candidate has a strong background as a basic scientist (motor control) & physical therapist. This mentored project will enable him to develop into an independent clinical researcher. He will train intensely in 6 areas: 1) stroke pathology, 2) motor learning applications to stroke, 3) virtual reality as a therapy delivery tool, 4) TMS as a neuroplasticity assay tool, 5) grantsmanship, and 6) biostatistics in clinical research. Research environment: The resources & support at UMDNJ & Columbia (the candidate's & mentor's institutions) is outstanding. UMDNJ has freed the candidate from teaching to devote at least 80% of his time to the project & 3 days/week at the mentor's lab. World recognized experts will make up the mentorship team. These ingredients should put him in a unique position to develop into a strong & independent clinical researcher.

Public health relevance
Public Health Relevance: The multidisciplinary project is a merger of biomedical engineering, rehabilitation, neuroscience, and motor learning. Knowledge gained will have far reaching implications in public health by: 1) describing the potential for brain reorganization after stroke, 2) making intervention more accessible to stroke patients (by adapting this method to a home-based system), and 3) improving the quality of empirically-proven rehabilitation. __SpecificAimsTextDelimiter__ that visual feedback can be used to provide the brain with interpretable sensory information thereby shaping better motor commands. We will use a battery of impairment-, function-based, and Transcranial Magnetic Stimulation-induced motor evoked potential (MEP) measures to probe how selective learning in VR benefits behavior and neural reorganization. Aim 1. Can focused attention to salient movement errors (error-based feedback) aid recovery of finger individuation? Impaired finger individuation after stroke is partly attributable to dysfunctional surround inhibition mechanisms in the motor areas and/or to lost corticomotomeuronal projections. Aim1 asks: Can attention be focused on the most salient motor enors by removing distracting feedback in order to restore finger individuation via surround inhibition mechanisms? 30 patients (experimental & control group) will practice (1 hour, 5x/week, for 2 weeks) precision grip, power grip, and sequential finger movements in VR. A data glove wom by subjects will relay 16 joint angles of the hand to a computer which will provide real-time visual feedback via motion of a virtual hand. Four of the virtual flngers will be locked in their start position while the remaining finger will move veridically to the subjects' corresponding finger. Thus, feedback will be focused to one unlocked finger (in a pseudorandom fashion). We hypothesize that this feedback will benefit finger individuation deficits and renormalize cortico-cortical interactions mediating surround inhibition, which will be evaluated with TMS (see Design & Methods). Aim 2. Can 'proper' visual feedback (errorless feedback) operantly shape better hand coordination patterns? Skill acquisition after stroke is hampered by error-prone movement and noisy feedback. Aim2 tests if experiencing 'proper' visual feedback can operantly shape motor commands and reduce subsequent movement errors. 30 patients (experimental & control group) will train as in Aiml. We will make visual feedback of the virtual hand 'proper' by applying a scaling factor to motion of each virtual finger in proportion to subjects' ability (see Design & Methods), similarly to how robot-assisted therapy provides graded force- assistance. In order to shape the motor pattern "from scratch", the scaling factor will be large on the first session and titrated in 10% steps. Thus, subjects' motor responses will be operantly shaped by a step-wise reduction of the scaling factor. We hypothesize that this feedback will be of greatest benefit to patients with a primary deficit in hand coordination. Accordingly, we expect paired pulse-TMS to show restored intracortical facilitation and inhibition in Ml. Aim 3. Does virtual mirror visual feedback reduce hand paresis. Severe hand paresis generally canries a poor prognosis of functional recovery after stroke and precludes patients from practicing skills. Work in the laboratory of the mentor (Dr. Krakauer) has shown that preceding practice with the less-affected hand may have beneficial carryover to the affected hand, suggesting that under certain conditions, the contralesional hemisphere may be able to relay 'proper' motor commands interhemispherically. Along these lines, we ask: can 'proper' visual feedback of the affected hand (illusory feedback in VR) paired with 'proper* motor commands relayed from the intact hemisphere also aid recovery of paresis? 30 patients (experimental & control group) will train as in Aim1 using their unaffected hand with real-time visual feedback of the virtual hand corresponding to the affected side (as a virtual mirror reflection). In line with our preliminary fMRI data, we predict that this feedback may be of most benefit in patients with moderate to severe paresis, reflected in increased force production and improved grip force scaling. Accordingly, we predict a reduction in the MEP threshold and expansion of the cortical territory in M1 that represents the hand muscles. Broader Impact. This project will enhance the candidate's training in new areas, including stroke therapeutics, motor learning, virtual reality applications for rehabilitation, and neural plasticity. The knowledge gained from this project will have important implications for understanding brain reorganization after stroke and greatly increase the impact of rehabilitation on hand impaimient. 52